Training in Microbial Pathogenesis and Genomics

This application is a new submission for our Microbial Pathogenesis and Genomics training program, which
was previously supported by a T32 from 2006-2016. We are requesting support for five predoctoral trainees
per year. The program, which is based at the University of Pennsylvania and Children's Hospital of
Philadelphia and is located on a single contiguous campus, includes twelve laboratories directed by well-
established principle investigators and three "junior investigators", who are newly appointed assistant
professors. Based on the success of the previously funded program, this T32 will enable us to continue to
recruit some of the best and brightest trainees from a talented pool at Penn and from a vibrant biomedical
environment that offers a large number of outstanding research opportunities for students. The organized
training mission of this T32 has helped our efforts to collaborate and interact more effectively as a group; our
trainers have several joint NIH grants, numerous joint publications, and a network of robust collaborations that
involve our trainees. Our research in progress meetings and seminars within the microbiology program have
helped spur the rapid growth of exciting, collaborative work in bacterial pathogenesis, microbial
immunopathogenesis, and bacterial metagenomics, with institutional support for deep-sequencing facilities,
bioinformatics, and a germ-free mouse core playing important roles in these efforts. These resources have
been expanded to the new Penn-CHOP Microbiome Program, which will be a major focal point for new
research and collaborations within our T32. The retention rate of our previously funded program was perfect;
no trainee left the program prematurely over the 10 years of funding. In addition, all of our former trainees
have continued to work in Microbiology or closely related fields involving infectious diseases. Five of our
previous trainees have obtained tenure-track faculty positions – all at major universities. The research
opportunities provided by the trainers in this program coupled with strong institutional commitment and an
extensive and well-organized training program will continue to provide excellent predoctoral training in
microbial pathogenesis and genomics.

Public health relevance
This application is for the new submission for our Training Program in Microbial Pathogenesis and Genomics. This program will take advantage of the resources of the UPenn community to train a talented group of students to further our understanding of microbes in health and disease.